Integrative functional genomic study of pathways impacted by recurrent autism CNV

SUMMARY Copy number variants (CNVs) and de novo mutations represent significant risk factors for Autism Spectrum Disorders (ASD). One of the most frequent CNVs involved in ASD is a deletion or duplication of the 16p11.2 CNV locus, spanning 29 protein-coding genes. Despite the progress in linking 16p11.2 genetic changes with the phenotypic (macrocephaly and microcephaly) abnormalities in the patients and model organisms, the specific molecular pathways impacted by this CNV remain unknown. In our recent study we demonstrated that KCTD13, a gene within the 16p11.2 locus, is co-expressed and physically interacts with Cul3 ubiquitin ligase primarily during late mid-fetal cortical brain development. This interaction may be crucial for regulating the levels of a small GTPase RhoA, a major regulator of actin cytoskeleton and cell migration. Based on these results, we propose the hypothesis that functional impact of the 16p11.2 CNV is manifested through dysregulation of the RhoA and downstream signaling pathways including neuronal migration, cytoskeletal dynamics, proliferation and apoptosis. We will test this hypothesis using existing 16p11.2 (Horev, 2011; Portmann, 2014) and developing new KCTD13 and Cul3 mouse models with CRISPR/Cas9 technology. To investigate cellular and molecular pathways impacted by the 16p11.2 CNV, we will apply integrative functional genomics approaches including genome-wide transcriptomic and proteomic profiling of the embryonic and early postnatal brain tissues. The goal of this project is to develop better understanding of the relationships between brain size and the 16p11.2 deletion/duplication genotypes, and to determine the detailed cellular and molecular mechanisms responsible for brain size differences. We will achieve this goal through the following Specific Aims: (1) Generate KCTD13 and CUL3 mouse models using CRISPR/Cas9 system and characterize cellular phenotypes in the developing brain; (2) Investigate molecular impact of the 16p11.2 CNV, KCTD13 and CUL3 mutations to identify dysregulated pathways; (3) Characterize behavioral phenotypes of the developed mouse models and test pharmacological inhibitors for phenotype reversal. This project will address an important but yet unresolved question regarding cellular and molecular pathways disrupted by the most frequent CNV implicated in multiple neurodevelopmental disorders. These pathways may represent high priority targets for future therapeutic interventions in ASD.

Public health relevance
NARRATIVE Our study will help to gain insights into a molecular mechanism of ASD that is impacted by the 16p11.2 CNV deletions and duplications and Cul3 ubiquitin ligase mutations. By investigating transcript and protein level changes as a result of these mutations, we will uncover a pathway that may represent a high priority target for future therapeutic interventions.